Sentinel Enhanced Dengue Surveillance System (SEDSS) Sites to Evaluate the Epidemiology and Prevention of Dengue and other Acute Febrile Illnesses in Puerto Rico

? DESCRIPTION (provided by applicant): The global burden of dengue is large with an estimated 50 million infections per year occurring across 100 countries. Puerto Rico, a Commonwealth of the USA, has the largest US population with endemic dengue. The island offers a unique opportunity to study the epidemiology, outcomes and prevention of dengue, as well as its clinical presentation and how dengue can be differentiated from other Acute Febrile Illnesses (AFI), such as chikungunya, transmitted by the same vector. The Saint Luke's Episcopal Hospital and Ponce School of Medicine Consortium has implemented a Sentinel Enhanced Dengue Surveillance System (SEDSS) through a Cooperative Agreement with the CDC that serves as a model of enhanced surveillance and an effective research platform to conduct studies on dengue and other AFI. Lessons learned from SEDSS implementation have been applied to this proposal to support and improve on the current enhanced surveillance site and to build on its strengths. The new project: Sentinel Enhanced Dengue Surveillance System to Evaluate Dengue Epidemiology, Outcomes and Prevention (SEDSS-EDEOP) will work to sustain the interest and commitment of hospital's administration, foster collaboration between the medical school, the public health program, the hospital and the community, as well as develop research capacity in medical residents, and medical and public health students that will create the future of dengue research in Puerto Rico. In addition to enhanced surveillance, the SEDSS-EDEOP Project will develop a comparative effectiveness research program to study dengue management strategies in a real world setting. This program should yield information on best practices that can be applied by clinicians to improve dengue outcomes. The SEDSS-EDEOP Project is likely to result in a model of enhanced epidemiologic surveillance and a strong research platform for studying dengue and AFI and the impact of primary and secondary dengue prevention strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE: The global burden of dengue is large with an estimated 50 million infections per year occurring across 100 countries (Simmons, 2012). Puerto Rico, a Commonwealth of the USA, has the largest US population with endemic dengue. The island offers a unique opportunity to study the epidemiology, outcomes and prevention of dengue, as well as the clinical presentation and how dengue can be differentiated from other Acute Febrile illnesses (AFI), such as chikungunya, transmitted by the same vector. Since 2012, enhanced surveillance has been implemented at Saint Luke's Episcopal Hospital (SLEH) in Ponce and Guayama, through a cooperative agreement with the Centers of Disease Control and Prevention (CDC) and in collaboration with Ponce School of Medicine (PSM) and the Public Health Program (PHP) of the Ponce Health Sciences University. SLEH and PSM constitute a Consortium for the conduction of medical education and research. The Sentinel Enhanced Dengue Surveillance System (SEDSS) was established to perform surveillance for dengue and other AFI as an alternative to the passive surveillance system that has limitations of underreporting and inconsistent clinical and outcome data collection. In its first two years, SEDSS was able to enroll 5,325 case subjects, 23% of AFI patients that presented at both institutions. Half of all AFI cases had a pathogen detected and most cases were caused by either a DENV, a viral respiratory pathogen, or an enterovirus. SEDSS has also proven a strong research platform from which to study clinical manifestations, diagnosis, treatment and outcomes of dengue and AFI. We are applying for the Sentinel Enhanced Dengue Surveillance System Sites to Evaluate the Epidemiology and Prevention of Dengue and other Acute Febrile Illnesses in Puerto Rico Funding Announcement (RFA-CK-15-002) based on the SLEH and PSM Consortium experience in implementing enhanced epidemiologic surveillance in southern Puerto Rico and promoting research in dengue and other AFI. Funding for the new project: Sentinel Enhanced Dengue Surveillance System to Evaluate Dengue Epidemiology, Outcomes and Prevention (SEDSS- EDEOP) will support and improve on the current enhanced surveillance site by sustaining the hospital's buy-in and commitment to the initiative, fostering collaboration between the medical school, the public health school, the hospital and the community, and building research capacity in medical residents and students to become our future clinician -scientists. In addition to enhanced surveillance, the Project will develop a comparative effectiveness research program to study dengue management strategies in a real world setting. The program should yield information on the best practices that can be applied by clinicians to improve dengue outcomes. The SEDSS-EDEOP Project is likely to result in a model of enhanced epidemiologic surveillance and a strong research platform for studying dengue and AFI and the impact of primary and secondary dengue prevention strategies, including clinical practices.